“Role of Maternal Obesity in Epigenetic and Metabolic Programming and Lower Respiratory Infection Risk in Early Life”

PROJECT SUMMARY/ABSTRACT
Dr. Maria Gutierrez is a pediatric allergist, immunologist, and rheumatologist at Johns Hopkins University (JHU).
This K23 application will allow Dr. Gutierrez to develop an innovative clinical and translational independently-
funded research program focused on the mechanisms of epigenetic and metabolic regulation of human immunity
during early life. Her short-term goal is to investigate the association of maternal obesity and the increased risk
of lower respiratory infection (LRTI) in infancy. Her preliminary data in 2,608 children from the Boston Birth
Cohort (BBC) recently identified that the increased LRTI risk in infants born to obese mothers is independent of
infant sex, race, gestational age, maternal smoking, parity and breastfeeding. Based on these findings, the
central hypothesis of this proposal is that maternal obesity induces fetal epigenetic and metabolic alterations that
disrupt early life immune development and lead to increased LRTI susceptibility in infancy. To test this
hypothesis, she will leverage the prospective data of the BBC that includes comprehensive clinical information
linked to DNA methylation (DNAm) and metabolomic profiles (liquid chromatography-tandem mass
spectrometry) obtained at birth (cord blood) in ~1,000 mother-infant dyads. Two specific aims are proposed: (1)
To test the hypothesis that maternal obesity alters the fetal immune epigenome (DNAm) leading to increased
susceptibility to LRTI in infancy; (2) To test the hypothesis that maternal obesity dysregulates fetal metabolic
pathways associated with the development of LRTI in the first year of life. Upon completion of this project, Dr.
Gutierrez will have acquired essential training and experience in 1) computational analysis of high-throughput
datasets used in human immunology studies with a particular focus on epigenetic and metabolomics data; 2)
novel methods of DNAm-based cell deconvolution to characterize cell-specific molecular epigenetic programs
influenced by the environment; 3) advanced statistical design and analysis of longitudinal cohort studies; 4)
leadership skills needed to lead an interdisciplinary research team and secure independent R01-level funding.
Dr. Gutierrez will achieve her research and training goals through formal coursework, workshops, national
meetings, and mentored research. Her primary mentor for this K23 award is Dr. Xiaobin Wang, the founder and
director of the JHU Center on the Early Life Origins of Disease and PI of the BBC. Dr. Wang is an experienced
mentor and international leader in molecular epidemiology who has made seminal contributions defining
epigenetic and metabolic predictors of childhood health. The mentorship team is comprised of experts in pediatric
allergy and immunology research (Dr. Robert Wood), computational biology (Dr. Xiumei Hong), and
developmental immunology (Dr. Steven Desiderio and Dr. Kathleen Sullivan). This training plan, and the data
generated from this proposed project, will provide the foundation needed to become an independent clinician-
scientist studying the epigenetic and metabolic regulation of the development of the immune system in early
human life and its long-term influence during health and disease.

Public health relevance
PROJECT NARRATIVE The goal of the proposed research is to investigate molecular mechanisms by which maternal obesity, which affects over 50% of U.S. pregnant women, is linked to an increased susceptibility to early life lower respiratory tract infections, the most common cause of hospitalization in U.S. infants. This new knowledge will be highly relevant to understand, prevent, and manage LRTI in early life and help reduce the disproportionally high respiratory morbidity and mortality in this vulnerable age group.